Targeting the Muscle Metaboreflex to Optimize Exercise Capacity in Stroke Survivors

Stroke survivors are unable to adequately increase and sustain cardiovascular drive during exercise, which limits
their capacity to exercise at high intensity. This is clinically meaningful because recent studies indicate that high
intensity exercise training (≥70% heart rate reserve, HRR) causes large motor gains post-stroke. However, a
central challenge is getting stroke survivors to achieve and sustain sufficiently high heart rates to exercise at
high intensity, and sessions can be limited to short bouts of exercise versus a continuous effort. An overlooked
mechanism of reduced exercise capacity post-stroke is the dysregulation of sympathetic reflex pathways during
exercise. When muscles become metabolically active, metabolites accumulate in the muscle. These metabolites
are sensed by group III/IV afferent nerves, which signal to brain centers to increase sympathetic outflow, resulting
in increases in cardiovascular drive to maintain adequate blood flow to the exercising muscle. Activation of this
“metaboreflex” is thus vital to drive the proper hemodynamic response to exercise. Our central hypothesis is that
in stroke survivors reduced activation of skeletal muscle in the paretic leg results in an impaired metaboreflex
during exercise, limiting exercise capacity. In Aim 1 we will establish impairment of the muscle metaboreflex in
chronic stroke survivors and determine the relationship with voluntary muscle activation and muscle metabolite
accumulation during exercise. We will test two hypotheses, 1) that the muscle metaboreflex is impaired in the
paretic leg compared to the non-paretic leg and vs. matched controls, and 2) that in the paretic leg, the magnitude
of metaboreflex activation will be positively correlated with voluntary activation of the muscle and the
concentration of metabolites during muscle contractions. In Aim 2 we will determine the relationship between
metaboreflex activation and exercise capacity, and test two hypotheses, 1) that there will be a positive
relationship between the magnitude of metaboreflex activation and both maximum heart rate and peak workload
during a graded exercise test, and 2) that stroke survivors with greater metaboreflex activation in the paretic leg
can spend more time exercising at ≥70 % of their HRR during a high intensity walking task. Finally, in Aim 3 we
propose a prospective, randomized, controlled, double-blinded crossover clinical trial designed to determine if
ischemic conditioning (IC) can improve metaboreflex activation in the paretic muscle and whether improvements
result in better performance during a high intensity walking task. We will test two hypotheses, 1) that in chronic
stroke survivors IC causes acute improvements in muscle metaboreflex activation and increases the time spent
exercising at heart rates ≥70% HRR during a high intensity walking task, and 2) that following IC, stroke survivors
with the largest increases in metaboreflex activation also show the largest increases in time spent exercising at
heart rates ≥70 % HRR during the walking task. Successful completion of this study could identify impairment of
the metaboreflex pathway as a primary cause for reduced cardiovascular drive during exercise post-stroke and
establish IC as a rehabilitation adjunct to optimize the cardiovascular response to exercise in stroke survivors.

Public health relevance
Project Narrative Because of damage to the brain’s motor centers, many stroke survivors are not able to fully activate the muscles in their legs, which may lead to a reduced cardiovascular response during exercise and inability to exercise at an intensity needed for functional gains. This study will examine if a feedback process that typically senses metabolites in the muscle to increase cardiovascular drive during exercise, called the metaboreflex, is impaired post-stroke and how that response relates to muscle activation and the ability to exercise at high intensity. Finally, we will use a safe and simple non-invasive intervention called ischemic conditioning, which has known effects to improve paretic muscle activation, to determine if metaboreflex sensitivity, cardiovascular drive and exercise tolerance can be improved.